Cell mechanobiology in confinement using an integration of bioengineering, materials systems and in vivo models

Project Summary – no change from awarded project.

Public health relevance
Project Narrative – no change from awarded project.